HEPARIN VS SALINE FOR PERIPHERAL IV LOCKS IN NEONATES

To compare the longevity of peripheral IVs that are flushed with 0.9% sodium chloride, 2 u/ml heparin sodium, or 10 u/ml heparin sodium in neonates.